Immunophenotypes in the Idiopathic Inflammatory Myopathies

PROJECT SUMMARY
Candidate: Dr. Erin Wilfong, M.D., Ph.D. is a Clinical Instructor at Vanderbilt University Medical Center in the
Divisions of Allergy, Pulmonary, & Critical Care Medicine and Rheumatology & Immunology. She has a strong
clinical background in both rheumatology and pulmonology with an excellent scientific foundation in chemical
biology and translational immunology from both her Ph.D. studies and her post-doctoral research studies
following clinical training. Her long-term career plan is to become a leading physician-scientist in inflammatory
myositis focused on the use of cutting-edge technologies to identify disease pathogenesis and novel
therapeutic targets. To achieve this, her immediate goal is to (1) learn the requisite bioinformatic techniques to
independently analyze high-dimensional immunophenotypic and transcriptional profiles and integrate these
profiles with clinical outcomes, and (2) apply molecular immunology techniques to determine dysregulated
pathways in IIM-specific cell populations.
Research Project: This proposal will study the underlying immunologic heterogeneity of IIM and identify
associations between immune/transcriptional signatures and clinical characteristics. Dr. Wilfong will (1) identify
immune signatures and transcriptional aberrancies in IIM using a cross-sectional IIM cohort and (2) correlate
immune features with ILD progression in a longitudinal IIM cohort. She will also take a prior single-cell RNA-
Seq finding and (3) perform mechanistic studies investigate how upregulation of the redox sensor TXNIP alters
immunometabolism in Jo1+ anti-tRNA synthetase syndrome.
Career Development: Dr. Wilfong’s career development plan integrates formal coursework with personalized
training from her mentors and collaborators to: (1) master R programming to facilitate analysis of
immunophenotypic and transcriptional datasets using cutting-edge analytic tools, (2) learn biostatistical
principles necessary to appropriately correlate immunology findings to clinical phenotypes, (3) characterize
cellular function using in vitro assays, and (4) develop the leadership and communication skills necessary to
become a principal investigator who applies the scientific findings and methodologies from this K08 award
towards a future translational immunology R01.
Environment: VUMC is the ideal environment to foster Dr. Wilfong’s development as a leader in translational
immunology and inflammatory myositis. Dr. Wilfong’s mentoring team includes experts in inflammatory
myositis (Crofford/Aggarwal), immunometabolism (Rathmell), single-cell RNA-Seq (Kropski), and
computational immunology (Georgiev). In addition to having the necessary mentors and equipment, 71.3% of
Vanderbilt University Medical Center career development award recipients (n=236) have successfully received
R level funding since 1999. Drs. Crofford and Rathmell have successfully trained many physician-scientists
and will ensure that Dr. Wilfong becomes an independently funded physician scientist.

Public health relevance
PROJECT NARRATIVE The idiopathic inflammatory myopathies are rare orphan disease that are hallmarked by the presence of various autoantibodies each with their own unique clinical phenotype. In this proposal, we utilize human peripheral blood mononuclear cells (PBMCs) from patients with IIM and healthy controls to understand the immune signatures and transcriptomics that drive IIM pathogenesis. We will also take the prior discovery that Jo1+ patients overexpress the redox sensor TXNIP and ascertain how TXNIP overexpression alters B cell metabolism.